Innate-Adaptive Immunoregulation in Liver Transplant Ischemia/Reperfusion Injury

OVERALL – ABSTRACT
Orthotopic liver transplantation (OLT) is the accepted treatment in patients with end-stage liver failure and those
with tumors of hepatic origin. However, the organ shortage has prompted the use of extended criteria donors,
which are particularly susceptible to ischemia-reperfusion injury (IRI). The overarching hypothesis of this P01
renewal is that IRI in OLT results from impaired regulation between donor liver-specific and host-derived innate
immunity. The project and core objectives, functioning in a highly synergistic manner, are to 1/ identify new target
molecules for improving donor liver quality (organ rejuvenation); 2/ provide novel therapeutic means against
acute IR-stress while promoting inflammation resolution (homeostatic reparation); and 3/ prevent sustained/
chronic inflammation to mitigate alloimmunity and improve outcomes (tolerance induction).
Project 1 focuses on a newly discovered CEACAM1 (CC1) negative checkpoint regulation of IR-triggered innate
immune activation/sterile inflammation in the mechanism of donor liver rejuvenation. Aim 1 and 2 will delineate
mechanisms by which enforced CC1 alternative splicing in the donor liver (S-isoform), or the recipient-derived
neutrophils (L-isoform) exert anti-inflammatory/cytoprotective functions in mouse IRI-OLT (synergy: Project 2/3).
Aim 3 will elucidate whether/how modulation of hepatic CC1 might improve the function of discarded human
livers (deemed untransplantable) when subjected to normothermic machine preservation (synergy: Project 3).
Project 2 defines mechanisms by which reprogramming of IR-stressed mouse liver-infiltrating macrophages and
resident heterogeneic KCs orchestrate the restoration of hepatic tissue homeostasis. In synergy with Project 1/3,
Aim 1 will determine the functional mechanisms by which embryonic vs. monocyte-derived KCs promote liver
IR-inflammation resolution. Aim 2 will define MerTK-mediated pro-resolution effector pathways in the liver-
resident KCs. Aim 3 will dissect the roles of KCs in OLT settings and whether/how liver inflammation resolution
and its kinetics impact the activation of alloimmunity and putative acquisition of transplant tolerance.
Project 3 dissects the innate immune DAMPs and associated cofactors/PRRs driving myeloid cell plasticity in
human IRI-OLT patients. In synergy with Project 1/2, Aim 1 will determine the TLR7/NOD2 and TLR9 ligands
and signaling pathways mediating differential polarization of regulatory vs. inflammatory macrophages and
crosstalk with T cells. Aim 2 will assess the therapeutic potential of PRR inhibition/preconditioning to mitigate
myeloid cell activation and OLT-IRI. Aim 3 will elucidate the impact of DAMP/PRR endotypes on the generation
of alloimmunity and graft outcome, and potential transplantation tolerance acquisition.
The Projects will be supported by an Administrative Core (Core A), Mouse/Human Liver Surgery Core (Core B),
and Computational/Biostatistics Core (Core C). This P01 unifies the well-proven collective expertise of a highly
experienced and interdisciplinary group of investigators, well-versed in the study of organ IRI, basic immunology,
liver immunobiology, and organ transplantation, both experimental and clinical.

Public health relevance
OVERALL – NARRATIVE Ischemia-reperfusion injury (IRI) limits the success of orthotopic liver transplantation in patients with end-stage liver disease and those with tumors of hepatic origin. By using established mouse models of IRI, and analyzing human liver transplants, this translational Program Project seeks to address unmet scientific and clinical needs in the field of organ transplantation. The results have the potential to alter clinical paradigms by identifying the continuum of innate/adaptive immune phenotypes that can be used to select, monitor, and refine the practice of therapeutic interventions against IRI in transplant patients.